DIGITAL HEALTH SOLUTIONS FOR COVID-19: DIGITAL HEALTH PASS AND SMARTER CONTACT TRACING SOLUTIONS

The goal of this project it to develop both a contact tracing and secure data exchange tools. The contact tracing solution securely combines data from a variety of sources (including manual self-report data, mobile device surveys, wearable devices, electronic health records) to enable tracing of contacts with individuals that have tested positive for COVID-19. The data exchange solution is a secure mechanism that empowers users to control the data they share in the course of their return to normal activities, including the ability to provide a verifiable health status claim. These tools are to be used by employers, government agencies, and others to evaluate the risk of allowing individuals to return to normal activities and also the ability to trace user contact with individuals diagnosed with or suspected of having contracted COVID-19. Data collected under this project will be deidentified and securely transmitted to an NIH data hub.